ENERGY EXPENDITURE IN POST OBESE AFRICAN AMERICAN AND CAUCASIAN WOMEN

Available data suggest that if energy expenditure (EE) is involved in the etiology of obesity, the component of interest is activity-related EE (AEE). Most studies examining EE did not ensure stable conditions, include controls, or distinguish subjects according to ethnicity or obesity predisposition. We propose to use a carefully controlled model of the post-obese state by reducing obese black and white women to a normal-weight post-obese state, and by comparing them with never-obese controls. In these groups we will test the hypotheses that 1) reduced spontaneous AEE is a causative factor, rather than an effect, of the obese state, and that 2) the cause of reduced AEE is an underlying disorder of muscle substrate oxidation which, in turn, causes increased physiologic and perceived exercise difficulty in obese and post-obese persons, compared to never-obese and post-obese persons, compared to never-obese controls.